Evaluation of Treatment Underreporting Using SEER-Medicare Data

The primary objectives of this study are to (1) work closely with the SEER working groups and NCI to develop and implement algorithms that would be applied to SEER-Medicare data to identify oligodendrogliomas, female breast and endometrial, and prostate cancers diagnosed from 1992-2009 that received radiation, chemotherapy, hormone, and/or immunotherapy treatment; and, (2) define the process for incorporating additional information into the existing SEER treatment variables in SEER*DMS.